Predicting Tissue Specific Gli3 Regulatory Activity Using Hand2

Project Summary
The Hedgehog (Hh) signaling pathway is essential for normal embryonic development and when perturbed,
frequently results in human disease, including those that impact development of the craniofacial complex. The
Gli transcription factors are the downstream effectors of the pathway and have been the subject of much research
as they are associated with a number of craniofacial syndromes (e.g., Grieg cephalopolysyndactyly) and can
function as both transcriptional activators and repressors of the Hh pathway. Gli3 is most stable and abundant
as a repressor. Despite this, our recent work identified a specific and necessary role for Gli3 activator (Gli3A)
function during normal development of the mandible that requires additional regulatory inputs to convey a robust
Gli3A response. Little is known regarding what is required for Gli3, as a bimodal transcription factor, to function
as a potent activator during development. To address existing knowledge gaps in how full-length Gli3 is
converted into an activator, we engineered a set of endogenously epitope tagged alleles for Gli3. With these
novel tools we propose to: (Aim1) determine if/how chromatin accessibility modulates Gli3A function; (Aim2)
investigate the role of co-factors and regulatory grammar in regulating enhancer output; and (Aim3) unbiasedly
identify protein interactors of Gli3A within the nucleus. We will focus on craniofacial development, specifically
development of the mandible, as a relevant model for testing these principles given the requirement for Gli
activity during glossogenesis and mandibular skeletogenesis. This developmental system will allow us to
determine the requirement for chromatin accessibility, exhaustively interrogate the regulatory grammar, and
identify the constituents of the Gli3 activator complex. Recent technological advances will enable hypothesis
testing through single-cell analysis of chromatin accessibility and transcription profiles from mutants predicted to
have pioneering activity. To validate our findings, we will perform in vivo experiments to test enhancer activity
and apply CRISPR/Cas9 mutagenesis to functionally assess native binding site requirements. Collectively, our
studies will shed light on the regulatory principles governing Gli-directed cellular programs that when disrupted
can result in range of human disorders ranging from structural birth defects to cancer. Understanding how these
programs are deployed and interpreted during normal development has the potential to improve human health
through the expansion of therapeutic interventions that can help mitigate pathway dysregulation.

Public health relevance
Relevance to Public Health Craniofacial malformations are among the most common congenital defects affecting the human population. Understanding how gene regulation is controlled and impacted during normal and pathological craniofacial development is essential for providing better therapeutic interventions and improve human health.